TASK E07: CENTRAL DATA MANAGEMENT CENTER CUSTOMIZATION AND MAINTENANCE

This contract provides for the development and maintenance of a central database to store and make accessible the data generated under the In vitro Assessments for Antimicrobial Activity program.